Mechanistic Studies of Gut Dysfunction Exacerbation due to SARS-CoV-2 in HIV/SIV infected Individuals

Abstract
With more than 60 million SARS-CoV-2 -infected patients worldwide and nearly 1.5 million COVID-19-related
deaths recoreded thus far (November 25), the COVID pandemic is one of the most critical global health problem
ever known to humankind, and a major emergency in the US. COVID-19 disproportionately impacts elders or
subjects with pre-existing conditions. Considering that the majority of persons living with HIV and AIDS (PLWHA)
in the US are aged over 50 years and that even the younger PLWHA present with accelerated aging and multiple
comorbidities related to HIV-induced excessive chronic inflammation, it is expected that COVID-19 will be
particularly severe in this risk group. Similar to HIV, SARS-CoV-2 replicates in the gut, and patients with
gastrointestinal symptoms were reported to have a more severe outcome. The exact mechanism through which
SARS-CoV-2 impacts the gut health remains elusive, however it is very likely that the two viruses can potentiate
each other through exacerbation of the gut lesions. Here, we will test the hypothesis that exacerbation of
the gut dysfunction of the SIV-infected PTMs after SARS-CoV-2 superinfection occurs through triggering
excessive mobilization, activation and NETosis of neutrophils at mucosal site and consequent gut
collateral damages. Such a scenario will result not only in an increased risk of the PLWHA to develop more
severe forms of COVID-19, but also to a significant boost of HIV pathogenicity through (i) losing control of HIV
at mucosal sites; (ii) depletion of mucosal and systemic immune effectors; (iii) increases of mucosal and systemic
levels of inflammation; and (iv) enhancement of pre-existent SIV-related comorbidities. This innovative project is
designed to assess pathogenic pathways impacted by SARS-CoV-2 in the gut, to understand the natural history
of COVID-19 related to either triggering or exacerbating HIV-associated gut dysfunction and comorbidities. We
will identify risk factors that could prompt therapy changes in high-risk individuals, such as the PLWH. Our highly
translational project addresses key scientific questions identified as critical by the NIDDK, thus being highly
responsive to RFA 20-021.

Public health relevance
Narrative We will investigate the impact of SARS-CoV-2/simian immunodeficiency virus (SIV) coinfections on the pathological outcome of the two infections. The rationale is that both viruses target the gut, and that mucosal dysfunction may result in multiple sequelae and comorbidities related to persistent inflammation. By understanding the discrete mechanisms of the interactions of these two viruses, we may gain significant insight on the potential outcome of the SARS-CoV-2 infection in HIV-infected subjects, which already present with mucosal damage and persistent inflammation. We will thus identify risk factors that could prompt therapy changes in high-risk individuals upon exposure to SARS-CoV-2.